Homolog pairing in meiosis

Project Summary/Abstract
Chromosome abnormalities due to meiotic errors are a leading cause of birth defects and spontaneous
abortions in humans. Our overarching goal is to understand how the organization of chromosomes in the
nucleus contributes to the correct pairing, synapsis, and recombination of homologous chromosomes during
meiosis I prophase– and how infidelity in these processes lead to chromosomal abnormalities. The basic
mechanisms leading to homolog pairing, synapsis and recombination are well conserved. The study of a wide
range of organisms has ultimately led to insights into human gamete aneuploidy and infertility. We use two
model organisms, budding yeast and zebrafish, each providing a unique lens to address how the 3D
configuration of chromosomes is governed to accommodate the changes in the nuclear landscape throughout
meiotic prophase. Our work addresses three key questions in the field of chromosome biology: 1) How do
chromosomes balance the contributions of diffusive versus active motion, 2) How does movement promote
molecular transactions between chromosomes? And 3) how do cells sense and respond to unpaired meiotic
chromosomes to ensure reproductive fidelity? 1) To understand how chromosomes move, we will examine the
contributions of diffusion, constrained diffusion, and active motor-driven movement on chromosomal loci in
yeast by comparing data sets of XYZ coordinates of tagged loci over time using our newly developed imaging
pipeline. We will compare these outcomes with newly developed models of chromosome behavior based on
simple biophysical properties of polymers. We will test if the nuclear pore complex also contributes to
chromosome motion, building on our discovery of a role of the NPC in meiotic chromosome dynamics. 2) To
understand how the organization of chromosomes in the much larger vertebrate nucleus contributes to
effective homolog pairing we will build on our recent work in zebrafish showing the initial events of pairing and
synapsis all take place at the telomere bouquet, suggesting that pairing in the larger nucleus is accommodated
by temporally and spatially sequestering pairing factors in time and space. We will test if telomere attachment
or positioning at the nuclear membrane is important for pairing, and we will identify the epigenetic markers that
define pairing-competent features of chromosomes. 3) To understand how cells respond to unpaired
chromosomes and how does this response differ between species, and even between sexes of the same
species, we will take advantage of our recent findings that synaptic errors cause arrest in spermatogenesis in
zebrafish males. Furthermore, synaptic errors in females are tolerated, thus raising the tantalizing possibility
that the surveillance and silencing of asynapsed chromosomes checkpoints does not operate in zebrafish.

Public health relevance
Project Narrative Human reproductive health can be compromised both genetically or by exposure to myriad compounds found in prescription drugs, food containers and toxic waste products found in the environment. This work is significant because it will identify genetic and biochemical pathways that may be direct targets of these insults during gametogenesis. A detailed understanding of these pathways will aid in identifying the underlying causes of human infertility, birth defects and pregnancy loss by exposure to environmental contaminants.